STRUCTURE &FUNCTION OF RETINOIC ACID BINDING PROTEINS

The purpose of this research is to study the physical interactions that are important for binding of retinoic acid by various1 intracellular retinoic acid binding proteins.